Vitamin A metabolism in the adult lung

PROJECT SUMMARY/ABSTRACT
The current understanding of vitamin A metabolism in extrahepatic tissues is that hepatic retinoid stores are
mobilized as retinol bound to retinol-binding protein 4 (RBP4) and delivered through the circulation to the cells
where they are taken up and used for all-trans-retinoic acid (ATRA) synthesis and ATRA-mediated transcriptional
regulation. Our preliminary data challenge this paradigm and indicate that retinoids are delivered to the lung
predominantly via circulating lipoproteins, a previously ignored pathway for retinoid delivery involving the action of
lipoprotein-metabolizing proteins. We found from our novel studies employing single-cell RNA sequencing (scRNA-
seq) of cells possessing vitamin A fluorescence that lipofibroblasts (LFs), endothelial (ECs), and epithelial cells
(AECs) all accumulate retinoids in form of retinyl esters (REs) and all express key genes needed to allow for
postprandial lipoprotein-derived vitamin A uptake, storage, and intercellular transport. Moreover, our mouse model
studies compellingly establish that the mice lacking locally stored retinoids in the lung develop more severe acute
lung injury resulting in death due to the loss of alveolar barrier integrity and impaired surfactant production. This
occurs even though mice are fed a nutritional complete chow diet, circulating vitamin A levels are normal, and the
animals are not otherwise vitamin A-insufficient. These findings lead us to hypothesize that lipoprotein-derived and
locally stored cellular vitamin A is preferentially processed, as opposed to circulating or systemic retinol, for ATRA
synthesis and signaling via nuclear retinoic acid receptors (RARs). We are proposing in-depth studies to explore
the metabolic consequences of vitamin A transport and how local vitamin A stores are acquired, metabolized, and
processed to mount protective cellular responses. Aim 1 will delineate the mechanisms that allow ECs, LFs, and
AEC2s to take up, accumulate, and intercellularly transfer retinoids. We will determine how retinoids are taken up
by these cells from circulating lipoproteins and redistributed among them. This will be achieved by kinetic studies
employing tracer labeling of retinoids in mice lacking cell-specific expression of Lpl, Cd36, and Lrp1 as well as in
cultured mouse and human cells coupled with lipidomics analyses. Aim 2 will establish how alterations in vitamin
A stores, which are primarily located in intracellular lipid droplets of the LFs, define the transcriptional and
phenotypic identity of the LF population. Using scRNA-seq molecular profiling coupled with immunohistochemical
spatial analysis of labeled retinoid-containing LFs, we will characterize how exposure to lipoprotein-derived
retinoids defines quiescent and profibrotic LF identity in vivo. Aim 3 will determine the crosstalk mechanisms by
which LF-derived retinoids regulate ATRA-RAR-mediated cellular functions of ECs and AEC2s. Employing genetic
and pharmacological manipulations of retinoid signaling via RARs in AEC2s and ECs coupled with lipidomics
analyses, we will dissect the crosstalk mechanisms underlying the role of LF-derived retinoids in cell-specific ATRA
signaling to regulate endothelial barrier integrity and surfactant lipid production. To further define underlying ATRA-
RAR-mediated mechanisms, we will employ human AEC2s and ECs co-cultured with retinoid-containing LFs.

Public health relevance
PROJECT NARRATIVE We have made a number of unexpected observations regarding vitamin A storage and metabolism in important cells within the adult lungs and its critical role in maintaining lung health. The studies being proposed in this application are paradigm-shifting for understanding the mechanisms of how local vitamin A stores are acquired, redistributed and processed among the cells, and how these are understood by the research field. The outcomes of these studies will impact the current strategies, including nutritional interventions, aimed at alleviating lung disease.